BLRD Research Career Scientist Award Application

Research in the Kiser laboratory is focused on elucidating mechanisms enabling the first steps of vision
and using this information to gain an understanding of retinal diseases affecting veterans with the end
goal of developing effective therapeutics. To achieve these objectives, we employ an array of
experimental approaches ranging from atomic-level investigations of vision-enabling proteins to the
development and characterization of animal models of retinal diseases. Our investigations are focused
on gaining insights into retinal disease pathogenesis with the overarching goal of developing disease-
modifying therapies, which are currently extremely limited. Our research efforts can broadly be
categorized into five general areas, which I elaborate on below. 1) Retinoids and the visual cycle.
Major effort is lab is devoted to elucidating the molecular, cellular, and physiological processes that
underpin the first steps of vision. The lab is a world leader in the biochemistry and structural biology
of a crucial retinoid biochemical pathway operating in the eye known as the visual cycle. We have led
efforts to understand retinoid processing by the key visual cycle isomerase, RPE65. We have also made
important contributions to understanding the initiation and quenching of signaling by the retinal light
receptor known as rhodopsin. 2) Visual cycle modulation. We specialize in a therapeutic approach
known as visual cycle modulation that seeks to dampen the activity of the visual cycle with the goal of
modifying metabolic processes that are believed to drive retinal diseases including age-related macular
degeneration (AMD) and diabetic retinopathy (DR). Our studies range from structure-guided drug
design efforts to the testing of lead molecules in pre-clinical animal models. Our studies have succeeded
in obtaining compounds with pharmacological properties favorable for translation into human studies.
A related interest is in the development of synthetic retinoids for the treatment of retinal diseases. 3)
Animal models of retinal disease. The laboratory has made important contributions to developing
models of retinal disease including models of both dominant (late-onset) and recessive retinitis
pigmentosa. We have used these models to gain important and unexpected insights into disease
pathogenesis that have informed therapeutic strategies, including the applicability of gene therapy or
genome editing technologies. We have also developed a new tool to interrogate roles of the retinal
pigment epithelium in retinal biology and disease. 4) Carotenoid metabolism. We laboratory also
invests substantial effort into understanding the metabolism of compounds known as carotenoids that
serve both as precursors to the light-sensitive Vitamin A-derivative in the eye, known as 11-cis-retinal,
and serve a protective role within the macular region of the retina. We have unique expertise in
understanding the metabolism of carotenoids by enzymes called carotenoid cleavage dioxygenases
(CCDs). 5) Systems Pharmacology. We also contribute to a collaborative project involving VA
investigators that seeks to develop the concept of systems pharmacology for the treatment of retinal
diseases such as AMD and DR. The laboratory plays an important role in these projects through our
expertise in retinal disease models and clinical pharmacology.

Public health relevance
Visual perception is often cited as the most highly cherished among the modes of human sensation. Unfortunately, this key sensory mechanism is impaired or lost in several diseases of increasing prevalence in the veteran population, including age-related macular degeneration (AMD). Therapeutics for these conditions remain extremely limited and focused on intervention late in the disease progression. Research in my laboratory centers on processes occurring within the light-sensing region of the eye, known as the retina, that are fundamental for initiating visual experiences and are also of relevance to AMD and other retinal diseases. We study light-absorbing, Vitamin A-related molecules called retinoids and carotenoids that are subject to specialized handling and transformation within the eye. We are uncovering the fundamental mechanisms underlying these processes and using this information to develop disease-modifying therapies for retinal diseases.